Wrd promotes active zone stability through dephosphorylation of Coracle

Wrd promotes active zone stability through dephosphorylation of Coracle
Abstract
Active zones (AZs) are specialized membrane compartments at the nerve terminal that
orchestrate the release of neurotransmitters. AZs are structurally plastic as their number, size,
location and strength can each be dynamically modified by developmental cues and neural
activities. This form of structural neuroplasticity may play key roles in learning and memory, and
its dysfunction may cause cognitive impairment. However, we know very little about the
molecular mechanisms that regulate AZ scaffold dynamics. We found that synaptic PP2A/Wrd
phosphatase promotes AZ stability at the Drosophila NMJs, and is required for light-induced AZ
remodeling at the photoreceptor synapses and taste learning at the adult stage. Through a
comparative proteomic approach, we identified Coracle (Cora, mammalian homologue is called
protein 4.1), a hub protein that organizes intercellular junctions and membrane proteins, as a
key Wrd-specific substrate that could mediate the AZ scaffold dynamics. This proposal
addresses the following two questions: First, what are the roles of Coracle in synaptic
development and stabilization? Second, how does the dephosphorylation of Coracle by
Wrd/PP2A alter the action of Coracle at the presynaptic terminal? In Aim 1, we will define a
novel role of synaptically localized Cora in regulating AZ dynamics at the developing and mature
synapses, as well as learning and memory. In Aim 2, we will define how Wrd-mediated
dephosphorylation of Cora affects Cora-mediated action in regulating synaptic stability and
cognitive function.

Public health relevance
PROJECT NARRATIVE Our ability of learning and memory depends on the functional and structural plasticity of our neuron-neuron connections. The research in this proposal aims to define a novel dephosphorylation-dependent pathway that controls rapid and bi-directional structural modification of our neuron-neuron connections in response to developmental cues or neural activities. Therefore, our work could help us understand the structural basis of our cognitive function and explore treatment strategy for neurological disorders such as intellectual disability.